Building Research Capacity for Implementation of Outcomes Research and Evidence-Based trauma care after Mass Violence, in Ukraine.

Summary/Abstract
Millions of Ukrainians (both civilian and military) had been recently exposed to combat/war-related
trauma. The numbers of casualties are staggering. Based on UN data, even during the early, and
limited, conflict in Ukraine (2014-2021), it had been estimated that, 32% of individuals suffered from
PTSD, 22% Depression, and 17% anxiety, thus it is projected that hundreds of thousands of persons
are likely to develop debilitating trauma/stress-related mental health sequela. At the same time, the
situation with mental health care in Ukraine is critical. The country was under communist rule for 70
years, leading to chronic underfunding of health care in general and mental health in particular. Even
before Russian invasion, Ukraine had the highest levels of psychological distress among former Soviet
states, and there almost no mental health professionals trained in evidence-based care for trauma,
depression, anxiety, and even less so, investigators who can disseminate, implement, and assess the
fidelity, acceptability, and efficacy of these treatments. Thus building, trauma care research, and
implementation are so critical right now. In collaboration with leading psychologists and physician-
scientists in trauma care in Ukraine, and drawing on the expertise of US collaborators – world-renown
experts in research methodology, stress/trauma and evidence-based care, this project will implement a
set of trauma research training experiences. The goal is to transfer of knowledge pertaining to trauma
epidemiology, pathophysiology, research methods, and implementation of interventions that build upon
that scientific base. In the latter years of the program, we will mentor and collaborate in the design and
pilot testing of research projects that ultimately will have the potential for national dissemination. The
proposed program involves collaboration among faculty from 5 different US Universities (TAMU,
UThealth, University of Michigan, Emory and MUSC), National University of Kyiv-Mohyla Academy
(NaUKMA), and Zelenskaya Initiative office for Mental Health reform implementation. To implement a
set of interlocking training experiences which will include the following: (a) Yearly workshops (~ 70
attendees) held in Western Ukraine, for post-doctoral clinical scientists (b) ongoing continuous
education with Experts from US and Ukraine, including monthly online sessions, directed reading and
supervision (c) Three month-long intensive Summer School, for 16 advanced and committed Summer
Fellows to get in-depth training in research methodology and work with mentors in areas of common
interest, (d) In-country research projects that Summer Fellows will develop, with the support of long
term U.S. mentors, (e) Creation of a Research network comprised from Research teams led by
Summer Fellows, and supported by the other trainees

Public health relevance
Project narrative The recent Russian invasion of Ukraine exposed millions to severe stress/trauma, and the mental health sequela is tremendous while the resource and knowledge to implement evaluate and provide necessary care are extremely limited. In partnership with the premier academic institution in Ukraine, and Ukraine Government initiative focused on trauma research, this project will build research capacity to (a) incorporate trauma-based knowledge and treatment (b) build translational interventions that would utilize it trauma care (c) implement research to evaluate effectiveness. Capacity building would take place through in-country workshops, continuous learning, and research fellowship, with later- stage work aimed at changing policy at the national level about how to address this critical need